Acute brain injury and blood-brain barrier dysfunction in cerebral malaria (ABC)

ABSTRACT
Cerebral malaria (CM) is an acute neurologic complication of infection with Plasmodium falciparum malaria that
presents clinically as an unarousable coma. In CM, several pathogenic mechanisms interact to cause the
characteristic neurocognitive sequelae observed in a quarter of surviving children. Infected erythrocytes
sequester in the brain microvasculature leading to widespread inflammation, endothelial activation,
hypoxic/ischemic injury, glucose abnormalities, hemolysis and cellular injury, resulting blood-brain barrier (BBB)
dysfunction, which may interact to cause brain injury. We have found that elevated tau and other markers of
injury to neurons are elevated in blood circulation and associated persistent neurodisability in survivors of CM.
Further, these brain injury markers are associated with factors involved in the pathogenesis of CM, including
glucose abnormalities, cellular injury, and endothelial/BBB dysfunction. What remains unclear is how
intraerythrocytic parasites confined within the vascular space, cause injury to neurons without crossing the BBB.
Thus, there is a critical need for mechanistic studies to define interactions between factors involved in the
pathogenesis of CM leading to BBB dysfunction and neuronal injury. Animal and in-vitro BBB models have been
key in advancing our knowledge of CM pathogenesis but limitations of existing models include: 1) interspecies
variability of non-falciparum animal models, 2) use of endothelial monolayers that lack key components of the
brain parenchyma, 3) reliance on immortalized or primary brain microvascular endothelial cell (BMECs) that lack
physiologically relevant barrier properties and/or suffer from batch-to-batch variability. To overcome these
limitations, we have developed a multicellular BBB model comprised of human-derived BMECs, neurons, and
astrocytes. Using our multicellular BBB model, we propose to investigate neuronal injury and examine
interactions between factors involved in CM pathogenesis and biomarkers of brain injury. And we will validate
our brain injury biomarker data in a follow-up cohort of children with CM tested for cognitive impairments at 12-
months. We hypothesize that sequestration of IEs to BMECs results in BBB dysfunction and the subsequent
decrease of glucose availability and release of cellular injury marker lactate dehydrogenase (LDH) causing
neuronal injury, which is a predictor of persistent neurodisability in clinical CM. Our hypothesis will be testing by
the following specific aims: 1) evaluation of the impact of glucose deprivation, cellular injury, and endothelial
dysfunction on neuronal injury in an in vitro human-derived multicellular BBB model, and 2) evaluation of a panel
of brain injury biomarkers as predictors of neurodisability in clinical CM. Upon completion, this work will establish
our human-derived multicellular BBB model as the standard for investigating mechanisms underlying neuronal
injury, which we have shown to be a predictor of persistent neurodisability in clinical CM. Our model has the
potential to transform the field of in-vitro CM neuropathology by facilitating research into new therapeutic targets
to prevent or reduce future neurodisability after pediatric CM.

Public health relevance
PROJECT NARRATIVE In cerebral malaria (CM), parasite infected erythrocytes (IE) interact with the brain’s microvasculature and initi- ate a cascade of pathogenic events that result in blood-brain barrier (BBB) dysfunction and neuronal injury. We have found that elevated plasma levels of neuronal injury marker tau and UCH-L1 are associated with persis- tent neurodisability and factors involved in the pathogenesis of CM including glucose abnormalities, cellular injury, and endothelial dysfunction. Using an in vitro model of the BBB comprised of human-derived brain en- dothelial cells, neurons, and astrocytes, we will examine interactions between IE, the BBB, and pathogenic fac- tors in CM leading to neuronal injury, to facilitate research into new therapeutic targets to prevent future neuro- disability after clinical CM.